Outreach Core

ABSTRACT | OUTREACH CORE
The Outreach Core (OC) of the Ponce Health Sciences University-Moffitt Cancer Center (PHSU-MCC)
Partnership provides community outreach and education to improve cancer screening behaviors in underserved
populations. Currently, over 60 million persons identify as Hispanic/Latino (H/L), comprising almost 18% of the
continental United States (US) population, with an additional 3.1 million US citizens residing in Puerto Rico (PR).
Despite unique socio-cultural and biological characteristics in sub-ethnic groups, H/L populations tend to be
viewed in aggregate. Mexicans, Puerto Ricans, and Cubans are the largest sub-ethnic groups among US H/Ls.
Efforts to achieve equity require an approach rooted in the knowledge and incorporation of both the
characteristics and preferences of the specific communities. Indeed, one-third of H/Ls report that they obtain at
least some health information from community-based organizations. The overall goal of the OC is to increase
community cancer awareness, community engagement, and participation in cancer health disparities research
and outreach in H/L communities. Working closely with other Partnership cores and investigators, the team
proposes to elevate and expand its activities to facilitate reciprocal communication between community members
and partnership researchers through OC educational activities, training opportunities, supporting participant
recruitment efforts, and incorporation of the Community Advisory Panel (CAP) feedback on partnership research
projects. Together with community members and Partnership researchers, the OC will increase cancer
awareness, community engagement, and participation in cancer health disparities research in the H/L
communities served by MCC (in FL) and PHSU (in PR) through the following three Specific Aims: 1) To develop,
deliver, and disseminate cancer education and outreach activities to H/L community members to reduce cancer
health disparities. The team will deliver cancer education to H/L communities in PR and FL using evidence-
based programs through multiple delivery strategies and reflecting partnership research priorities and topics of
interest identified by community members. 2) To enhance capacity for mutually beneficial research engagement
to address cancer health disparities. The team will facilitate communication between community members and
partnership investigators (e.g., CAP Research Corner), support partnership research that is responsive to
community needs (translational research), promote community participation in the partnership’s research
activities/projects to reduce cancer health disparities, and train researchers and community members in
community engagement principles. 3) To expand the capacity to train community members as lay health
promoters to deliver evidence-based cancer education programs in their communities. The team will train
community members and community partners/organizations to deliver evidence-based cancer education (e.g.,
Cancer 101, OC activities) in their local communities to address cancer health disparities.